Regulating Pathogen-induced Protective and Pathogenic CD8 T cells in the CNS

Neurological diseases are a leading cause of death and disability, and despite diverse etiologies, share a
common theme of immunological dysfunction. The immune and nervous systems are finely tuned to both
sense and orchestrate responses to external stimuli. There are billions of neurons in the brain, yet we know
next to nothing about how brain neurons interface with the immune system in the CNS. Recent advances in
neuroimmunology include the discovery of meningeal lymphatic, roles for immune cells in CNS homeostasis
and characterization of tissue resident memory T cells (Trm) that persist in the brain after CNS infection. We
recently (Urban et al, Nature Immunology, 2020) provided evidence that Trm were also generated uniquely in
the brain after peripheral immunizations and infections, suggesting that processes unique to the brain may
foster Trm persistence in this organ after peripheral immunization. However, it is unknown if specific neuronal
pathways in the brain contribute to Trm generation or persistence in this organ and whether neuronal signaling
influences protection by CNS Trm.
Several CNS diseases in humans have immunological etiologies, with T cells thought contribute to the
pathogenesis of viral encephalitis (VE), cerebral malaria (CM) Thus, a second unknown is the role of brain
neuronal signaling pathways in T cell-mediated diseases of the CNS.
We will attack these problems using chemogenetics. Specifically, there are highly conserved neurons
within the brainstem, such as the dorsal raphe (DR), which project broadly throughout the CNS and activate in
response to immunity-relevant signals such as stress, pain, and itch. Transgenic B6 mice expressing SERT-
cre target DR neurons. Stereotaxic injection of adeno-associated viruses expressing flox/stop designer
receptors exclusively activated by designer drugs (DREADD), results in expression of the DREADD only in cre-
expressing neurons. Transduced cre-expressing neurons are detected by mCherry expression and can be
manipulated, depending on their nature (activating or inhibitory signals specified by the precise DREADD), by
injection of a designer ligand. We have obtained these mice and virus systems and provided proof of our ability
to perform the sophisticated stereotaxic surgeries and deliver the DREADD constructs to the targeted neurons.
We will use the chemogenetic technology and our capacity to evaluate CNS immunity and immune-mediated
pathogenesis to test the central hypothesis that brain neuronal signaling pathways contribute to the
generation, maintenance and function of CNS Trm and the outcome of T cell-mediated CNS diseases.
Specific Aim 1. Determine if DR neuronal signaling regulates the generation, maintenance or protective
function of brain Trm.
Specific Aim 2. Determine if DR neuronal signaling regulates CD8 T cell-mediated lymphocytic
choriomeningitis virus (LCMV) induced VE or experimental cerebral malaria (ECM).

Public health relevance
T cells in the brain can provide protection or cause disease and their control by specific neurons is not understood. This proposal will use sophisticated manipulation of specific neuronal signaling pathways and established models of brain T cell immunity and disease to address the interaction of these critical cell types.